Conserved mechanisms of ciliary signaling and cell-cell fusion

We use the bi-ciliated, unicellular green alga Chlamydomonas as a model system to study conserved
mechanisms of ciliary signaling and cell-cell fusion during fertilization. Ciliary adhesion between plus and
minus gametes induces a rapid, ~15-fold increase in intracellular cAMP in the cell body that leads to
activation of the cells in preparation for the gamete membrane fusion reaction. In our studies of ciliary
signaling, we are examining the functions of the protein kinase GSPK, the adenylyl cyclase IMP4, and the
protein phosphatase PP2A3 in the ciliary adhesion-induced increase in cAMP. One key assay in these
studies is measurement of ciliary adhesion-induced cAMP production in gametes expressing wild type and
mutant forms of the proteins. New fluorescent reagents are now being used in other systems to rapidly
quantify cellular cAMP levels in live cells and we anticipate that they can be used with flow cytometry to
quantify cAMP concentration in our cells. In studies of the mechanisms of gamete fusion, we showed that
interaction between the membrane protein FUS1 on the mating structure of activated plus gametes with the
membrane protein MAR1 on the mating structure of minus gametes leads to attachment of the two gametes
at their mating structures. We have demonstrated that MAR1 is bifunctional. Not only does MAR1 interact
with FUS1 during mating structure adhesion, but in resting minus gametes, MAR1 is biochemically and
functionally associated on the minus mating structure with the conserved class II membrane fusion protein,
HAP2. Unlike viral class II fusion proteins, however, whose fusogenic reconfiguration is triggered by low pH,
the fusogenic reconfiguration of HAP2 is triggered by FUS1-MAR1 interactions. We and our collaborators
have just determined the X-ray structure of the FUS1-MAR1 complex, showing that its is a heterotetramer
composed of two MAR1 monomers and two FUS1 monomers. We will use structure-guided mutagenesis in
combination with phenotypic analyses to identify the structural domains and specific residues in FUS1,
MAR1, and HAP2 important both to maintain them in their prefusion forms and to regulate their function
during the fusion reaction. We have just determined that a flow cytometry-based assay for cell-cell fusion is
20 times faster than our current microscopy-based assay and allows us to assess 30,000 cells/per sample
compared to 300 cells/sample in our microscopic assay. The currently available flow cytometer is well past
its prime, is unreliable, and lacks the laser technology needed for newly available fluorescent probes. Here,
we are requesting funds towards the purchase of a new Becton Dickinson Symphony A1 Flow Cytometry
system that we believe will substantively enhance the efficiency and thorougness of our research.

Public health relevance
Project Narrative: We request supplemental funds to purchase a Becton Dickinson Symphony A1 Flow cytometer to increase the efficiency and thoroughness our analyses of individual stages in Chlamydomonas fertilization. Our currently available flow cytometer is nearly 15 years old and unreliable, and lacks the laser needed to exploit newly available fluorescent reagents for detecting cell activation during fertilization. The new instrument would substantially enhance our ability to investigate conserved mechanisms of ciliary signaling and gamete fusion.